Using implementation science to adapt a targeted transportation intervention for patients with diabetic retinopathy (PRONTO-EYE)

PROJECT SUMMARY/ABSTRACT
Diabetic retinopathy (DR) is the most common cause of preventable vision loss in the U.S. and disproportionately
affects people with limited socioeconomic resources. Prompt diagnosis and treatment can prevent visual
impairment by up to 90%, making adherence to visits critical. The Social Vulnerability Index (SVI) is a validated
measure which has demonstrated the effects of neighborhood-level vulnerability on individual patient access
and outcomes. Increased neighborhood-level social vulnerability, measured using SVI, is associated with
increased risk of missed ophthalmology appointments. As SVI is being integrated into electronic health records,
there is now an opportunity to systematically identify individuals with high neighborhood SVI who are at increased
risk of missed appointments and subsequent vision loss. Dr. Scanzera previously identified transportation to and
from visits to be among the most consistent markers of social vulnerability that contributes to missed
appointments in patients residing in neighborhoods with high social vulnerability. The purpose of Dr. Scanzera’s
K23 research plan is to design, implement, and evaluate a ride-share transportation intervention adapted from
her health system’s existing PROgram for Non-emergency TranspOrtation (PRONTO) to mitigate barriers to
adhering to scheduled ophthalmology visits in patients with DR coming from neighborhoods with high social
vulnerability. She plans to integrate implementation science and human-centered design research strategies to
(1) Co-Design and (2) Pilot test PRONTO-EYE, which she hypothesizes will be successfully integrated into the
existing healthcare system and will improve adherence to ophthalmology visits in this population.
Dr. Scanzera’s long-term career goal is to develop and implement evidence-based interventions to reduce
preventable blindness in rural and urban settings in the U.S. The K23 Career Development Award will provide
her the mentored research as well as didactic and experiential training to become an independent investigator
using implementation science to work toward eliminating disparities in eye health. She will have access to
considerable resources through the University of Illinois Chicago, including mentors with expertise that each
complement her research proposal and career development. This K23 proposal directly aligns with the National
Eye Institute 2021 Strategic Plan which includes public health research as an area of emphasis. By developing
an intervention for patients with diabetic retinopathy residing in neighborhoods with high social vulnerability, Dr.
Scanzera’s research plan has the potential to improve access to eye care and eye health outcomes in those with
low socioeconomic status. The immediate deliverable will be a transportation intervention to improve adherence
to ophthalmology visits in patients with diabetic retinopathy residing in neighborhoods with high social
vulnerability which will be evaluated in a subsequent larger trial as part of an R01.

Public health relevance
PROJECT NARRATIVE Diabetic retinopathy is the most common cause of preventable vision loss in the U.S. and disproportionately affects people with limited socioeconomic resources. The proposed study will co-design, implement, and evaluate a ride-share transportation intervention, adapted from the existing PROgram for Non-emergency TranspOrtation (PRONTO), in patients with diabetic retinopathy residing in neighborhoods with high social vulnerability with a goal to increase adherence to scheduled ophthalmology visits as a critical step in reducing vision loss. This study will prioritize the association of social vulnerability with missed ophthalmology appointments to help guide a targeted patient-centered intervention.